Adaptation to Extracellular Acidosis by pH-Sensing eIF5A

Project Summary System-wide remodeling of protein synthesis is an important component of cellular stress adaptation. Recent, important studies support the observation that global translational adaptations (e.g. translation efficiency remodeling and alternative translation machineries) often predominate over transcriptional control and mRNA levels in controlling protein output. This phenomenon has been observed during evolution, development, differentiation, and especially during cellular adaptations to physiological stimuli. Acidification of the extracellular environment (extracellular acidosis) as a consequence of anaerobic metabolism is frequently observed in tumors. We, and others, have shown that extracellular acidosis induces cancer cell dormancy, an enigmatic phenotype involved in ischemic tolerance and cancer resistance to radiation and chemotherapy. An important question remains regarding: what are the sensing mechanisms and assets that enable translational adaptations in cells responding to variations in extracellular pH. Using our newly-developed, unbiased, biological activity- based MATRIX platform, I introduce in this grant proposal the “Acidotic Protein Synthesis Machinery”. Amongst the acidosis-enriched translation factors identified by MATRIX, eIF5A is, interestingly, the only one that can be traced back to the last universal common ancestor, which is believed to have relied exclusively on anaerobic metabolism. I will provide evidence that eIF5A operates as a pH-sensing transducer that is essential for the specialized protein synthesis machinery that facilitates acidosis-induced tumor cell dormancy. I will reveal unique acidosis-specific biomarkers derived from human cancer cell lines. Based on these preliminary data, I hypothesize that eIF5A is a pH-sensing transducer that drives tumor cell adaptation to acidosis via translatome reprogramming. We plan to test this hypothesis with the following specific aims: 1- Uncovering the adaptive, acidosis-specific translatome; 2- Characterize the role of eif5A in cellular adaptation to acidosis. Extracellular acidosis is a frequent but largely unexplored stimulus observed in an array of pathological settings, including cancerous tumor microenvironments. The proposal is innovative as it will discover: 1- an extracellular pH-sensing protein synthesis machinery, 2- an essential function in acidotic human cancer cells for the ancient eIF5A, 3- the translatome of cancer cells responding to variations in extracellular pH, 4- panel(s) of acidosis- specific protein markers that can be used to diagnose and/or prognose the acidotic state in experimental and human clinical samples; and 5- mechanisms of cellular dormancy involved in ischemic tolerance and resistance to mainstay anti-cancer therapy.

Public health relevance
Project Narrative Cancer is a leading cause of death in the US, and extracellular acidosis is an integral component of the tumor microenvironment. This project will globally uncover the adaptive proteins that are made in response to acidosis and the components of the translational machinery that allow these proteins to be made. These studies will uncover markers of the acidotic state and mechanisms of cellular dormancy induced by extracellular acidosis.